What is the role of blood-brain-barrier regional specificity in the nucleus accumbens?

PROJECT SUMMARY/ABSTRACT
The blood-brain barrier (BBB) is a term that describes the unique properties of central nervous system (CNS)
blood vessels which allow them to stringently regulate the extracellular environment of the surrounding neural
tissue. While it is known that different brain regions are made up of diverse cell types and execute distinct
functions, it is unknown if the BBB exhibits varied features in functionally distinct regions to regulate specific
neural circuits. Since little is known about heterogeneity of the BBB, this project will address this gap in
knowledge and pursue the question of whether regional specializations of the blood-brain barrier may regulate
local circuit function and behavior. This will identify if the BBB could be targeted to modulate specific behaviors,
including reward and addiction.
Single cell RNA sequencing revealed that there is significant inter-regional heterogeneity of the BBB via
differential gene expression in endothelial cells (ECs). While the canonical BBB genes that contribute to
restrictive barrier properties were expressed in ECs across all brain regions, many genes involved in transport,
signaling, and metabolism were found to be enriched in ECs of specific brain regions. For instance, Stra6, a
transport regulator of retinoids, is remarkably enriched in the nucleus accumbens shell (sNAc) and the ventral
cochlear nucleus (VCN) compared to other areas of the brain. The sNAc is particularly of interest because its
function in reward and reinforcement learning implicates the region in drug addiction. Due to the prevalence and
severity of addiction, it is urgently important to find new targets for treating this major public health issue by
asking if the BBB, via Stra6, plays a role in regulating addiction.
The proposed study will address this critical need by determining (1) if the regional specificity of Stra6 at the
BBB is necessary for the development or adult function of the sNAc, (2) by what molecular mechanisms Stra6
regulates sNAc function, and (3) if Stra6 is required for learning addiction behavior. This proposal will test the
hypothesis that Stra6 concentrates retinoids within the sNAc, thereby dynamically regulating dopamine receptor
levels and thus the adult function of the sNAc in both spatial learning and addiction. The importance of Stra6 at
the BBB will be tested using conditional, EC-specific Stra6 knockout mice to excise Stra6 during development
or in adulthood. These aims will also test whether elevating dietary Vitamin A, the source of retinoids, can
increase retinoid levels in the absence of Stra6 and rescue sNAc function. The central goals of this proposal are
to gain deeper understanding of the BBB’s contribution to brain function, specify mechanisms of addiction, and
assess what factors might increase individual susceptibility to drug addiction.

Public health relevance
PROJECT NARRATIVE This project proposal seeks to understand the heterogeneity of the blood-brain barrier (BBB) and how it might differentially control the microenvironment of functionally distinct brain regions. The results of this work will address fundamental questions about BBB differences in transport, metabolism, and signaling according to function, thus yielding critical knowledge about BBB dysfunction associated with neuropsychiatric diseases and aging. In addition, by specifically investigating the BBB role at the nucleus accumbens shell, we aim to study molecular mechanisms of addiction in hopes to uncover therapeutic targets for treatment or prevention.